Novel biomarker strategies for HCC early detection in AI/AN patients

ABSTRACT: PROJECT 1 – Novel Biomarker Strategies
Peripheral blood-based HCC biomarker panels are an essential component of early detection strategies,
especially in remote AI/AN tribal communities and Indian reservations that are very far from any imaging facilities.
Additionally, blood-based biomarker screening achieves greater compliance than imaging-based screening,
even when imaging is readily available.
Promising serum biomarker panels have been undergoing phase 2 and 3 studies of biomarker validation in the
last 5-7 years, such as the GALAD test by Fujifilm-Wako and the methylated DNA marker (MDM) panel by
EXACT Sciences, which raises the possibility of a “liquid biopsy” for early detection of HCC. Unfortunately, none
of these panels have ever been tested in AI/AN patients. It is likely that the performance of these biomarkers will
be significantly different in AI/AN patients than what was described in predominantly Caucasian populations in
whom they were developed.
The overarching aim of Project 1 is to use a translational approach to develop novel biomarker strategies for
early detection of HCC that are designed specifically for AI/AN through 3 interconnected specific aims:
SA1: Determine if hepatocellular carcinoma (HCC) in AI/AN patients is associated with unique or enriched
genomic and/or epigenomic alterations or patterns of alterations compared to other racial/ethnic groups in
order to identify molecular markers, including circulating free methylated DNA (cf mDNA) markers that can be
used for surveillance in AI/AN patients at risk of HCC.
SA2: (Phase 2 study of biomarker development). Perform a case-control study of 100 cases with T1 or T2
HCC (n=50 AI/AN, n=50 other racial/ethnic groups) and 100 at-risk control patients without HCC with cirrhosis
or HBV (n=50 AI/AN, n=50 other racial/ethnic groups) matched by liver disease etiology and cirrhosis severity,
to determine and compare the performance characteristics (sensitivity, specificity, AUROC) of the following
novel HCC screening biomarker panels:
• Circulating methylated DNA marker (MDM) panel (EXACT sciences)
• Serum protein-based biomarker panel GALAD (FujiFilm-Wako Diagnostics)
If necessary, we will modify GALAD to optimize its performance for AI/AN persons and consider if its
performance can be further improved by combining it with cf mDNA markers.
SA3: (Phase 3 study of biomarker development). Develop and validate HCC early detection algorithms in an
Alaska cohort of AI/AN patients with HCV-cirrhosis or HBV using longitudinal (serial) AFP or GALAD, or
modified GALAD developed in SA2 specifically for AI/AN patients, modeled by a Parametric Empirical
Bayesian (PEB) and Multivariate Fully Bayesian (mFB) approach.

Public health relevance
While deaths related to lung, breast, prostate and colorectal cancer have declined dramatically by 40-53% between 1990 and 2016, hepatocellular carcinoma (HCC) is the only major malignancy whose mortality is rising in both men and women and has had the highest average annual percentage change. American Indian/Alaska Native (AI/AN) people face a disproportionally high burden of HCC with 2.4 times higher HCC incidence and 2.5 times higher HCC-related mortality than white persons. Our aim is to apply novel, innovative, translational approaches to surveillance and early detection of HCC that are informed by unique aspects of HCC pathophysiology and epidemiology in AI/AN people in order to eliminate disparities, improve early detection and ultimately reduce HCC-related mortality.